De novo design and engineering of biological error correction

PROJECT SUMMARY / ABSTRACT
Biological systems have evolved a remarkable ability of error correction in processes essential for life. Non-
equilibrium mechanisms of kinetic proofreading increase the fidelity (correct versus incorrect outcomes) by
several orders of magnitude, beyond that expected solely from differences in equilibrium binding to correct
versus incorrect binding partners. Yet we are not harnessing this amplification of specificity in applications of
biological engineering. The central challenge and goal of this proposal is to pioneer approaches to engineer
mechanisms of biological error correction from the ground up that can be integrated generally into engineered
systems – for therapeutic purposes or biotechnology – to increase the fidelity of molecular recognition by 2-4
orders of magnitude. Natural error correction systems are complex, incompletely understood, and difficult to
manipulate. Here we will instead build generalizable systems de novo with proteins that are computationally
engineered to be tunable, controllable, and composable. Based on recent breakthroughs, including from our
laboratory, in the precision, accuracy, and complexity of de novo designed protein structures, functions, and
dynamics guided by deep learning, we posit that such a transformative advance might now be within reach. We
propose conceptual innovations in de novo protein design beyond the state of the field by engineering energy-
driven multi-step pathways that implement kinetic proofreading de novo to achieve error correction rivaling that
of natural systems. Specifically, we will conceptualize, build, and test generalizable computational approaches
to couple mechanisms of protein recognition, modification, conformational change, kinetically controlled
assembly, molecular event cascades, and energy consumption. We will build multiple instances of each protein
part, molecular function, and system-level behavior, with designed variation in quantitative parameters including
rates and affinities. Using in vitro reconstituted multi-protein systems, high-throughput quantitative assays, and
modular engineering of cells, we will assess molecular and system-level function using systematic and precise
targeted perturbation and parameter sweeps that will be integrated with and inform predictive modeling. Overall,
this ambitious plan will lay the foundation for groundbreaking new abilities to correct biological errors and amplify
specificity in engineered systems, enabling future advances across discovery science, biomedical applications,
and biotechnology.

Public health relevance
NARRATIVE Biology has evolved powerful error correction mechanisms to ensure the extreme fidelity of processes critical for life and human health: DNA replication, protein translation, cellular proliferation, and immune signaling. Inspired by nature, the planned research will develop generalizable strategies to build such error correction into human- engineered systems to drastically increase specificity (correct versus incorrect outcomes) in therapeutic and biotechnological applications. Examples range from highly sensitive diagnostics to tissue engineering to advanced cell therapies.